Sickle cell bone marrow niche and regulation of platelet activation and erythropoiesis

Platelets in both murine and human Sickle Cell Disease (SCD) are increased in number and activation state,
and likely contribute to the pathogenesis of SCD. Another complication of SCD is anemia, due to destruction of
red blood cells and altered erythropoiesis, including reduced expansion of erythroid progenitor cells and
increased mobilization of progenitors to the peripheral blood. The molecular mechanisms regulating platelet
production, activation and erythropoiesis in the sickle bone marrow remain elusive. We previously identified
Mesenchymal Stem Cells (MSCs) as key players in improving platelet formation and lowering baseline platelet
activation. MSCs secrete CXCL12, a key factor for promoting megakaryocyte migration and for maintaining
progenitor cells in the bone marrow. In our preliminary studies, we found MSCs also express Gas6, an important
factor for erythropoiesis and can synergize with and enhance EPOR signaling. In SCD, we demonstrated that
heme activation of Toll-like receptor 4 (TLR4) signaling in MSCs leads to reduced functionality, decreased
cytokine production, and increased apoptosis. Furthermore, it was previously reported that erythroid progenitors
are reduced in the SCD bone marrow and found at an increased presence in the peripheral blood, which we
confirmed in our preliminary studies. Thus, our overall hypothesis is that heme driven alterations in SCD MSCs
reduce Cx43, Gas6, and Cxcl12 expression and contribute to increased platelet activation, platelet production,
and impaired early erythropoiesis in SCD. In our first aim, we plan to investigate the contribution of MSCs to
elevated platelet formation and activation in SCD. Using a rigorous combination of human and murine samples,
in vitro co-culture studies, chemical inhibitors/antibody blocking assays, and in vivo genetic mouse models, we
will examine whether heme mediated activation of TLR4-NFB or ROS-Nrf2 in MSCs leads to reduced Cx43
expression and in turn promotes increased platelet production and baseline platelet activation in SCD. In our
second aim we will investigate the mechanisms by which MSCs have impaired support of erythropoiesis in SCD.
Using heme treated mouse models, heme scavengers, TLR4 inhibitors, and transfusions, we will examine MSC
ability to maintain erythroid progenitors in the bone marrow along with their ability to promote the proliferation of
early erythroid progenitor cells. These proposed studies will significantly contribute to the knowledge base of the
bone marrow niche at steady state and in SCD, which could initiate development of novel anemia treatments or
anti-platelet and anti-thrombotic drugs to reduce arterial thrombosis and benefit patients with SCD.

Public health relevance
We aim to investigate the role of bone marrow mesenchymal stem niche cells in promoting increased platelet activation, reduced erythroid progenitor cell maintenance and proliferation in sickle cell disease and examine the ability of transfusions to reverse this phenotype. These studies will provide new mechanistic insight into the role of the bone marrow microenvironment in the pathogenesis of sickle cell disease, and lead to new opportunities for therapeutic targeting of niche cells to lower platelet activation levels and improve red blood cell production.